Equipment and Administrative Supplement- THE HARC CENTER 2.0: HIV ACCESSORY AND REGULATORY COMPLEXES

ADMINISTRATIVE SUPPLEMENTS - THE HARC CENTER 2.0: HIV ACCESSORY AND
REGULATORY COMPLEXES
PROJECT SUMMARY
The primary goal of the HARC Center is the structural characterization of endogenous HIV-host protein
complexes involved in HIV restriction, transcription, and latency. HARC 2.0 is supported by four Technological
Cores that serve to apply and develop innovative methods for biochemical and structural characterization of
purified reconstituted complexes and dynamic endogenously purified complexes. In order to expeditiously
achieve this overall mission, the HARC Center is requesting $1,499,999 total ($1,134,084 Direct Costs;
$365,915 Indirect Costs) in supplemental funding on behalf of the Proteomics and Computational Cores and
Project 1 for (1) a critical piece of equipment, the Molecular Devices CellXpress.ai, an automated cell culture
system equipped with a cell line incubator, a liquid handler, and a high content imager ($500,000 Total Costs;
no Indirect Costs); (2) the generation of an atlas of HIV-host protein interactions, utilizing state-of-the-art
artificial intelligence tools and protein-protein interaction (PPI) mapping in primary human immune cells
($499,999 Total Costs; $305,654 Direct Costs, $194,345 Indirect Costs); and (3) the investigation of Vif
interactions with additional antiviral A3 family members ($500,000 Total Costs; $328,430 Direct Costs;
$171,570 Indirect Costs).

Public health relevance
ADMINISTRATIVE SUPPLEMENTS - THE HARC CENTER 2.0: HIV ACCESSORY AND REGULATORY COMPLEXES PROJECT NARRATIVE The following three supplements will support the HARC Center’s mission of using its powerful “Systems-to- Structure” platform to uncover HIV-host protein interactions and develop a comprehensive understanding of how HIV rewires the host cellular machinery and of key disease processes.